Facilitating supervised self-management of stimulant medications among adolescents: improving adherence, reducing stigma, and supporting caregivers

PillSmart: Abstract
Stimulant medications are efficacious in reducing impulsivity and other ADHD symptoms in youth,
which is important because youth with ADHD have an increased risk of developing substance use disorders.
Youth's non-adherence of stimulant medications is prevalent (~47-60%), and the misuse of prescribed stimu-
lants is increasing among youth (~5-34%), which poses a serious public health concern. Without adequate
monitoring support by parental caregivers, stimulant misuse and non-adherence in youth can increase the risk
of substance use disorders, overdose, psychosis, and suicidality. There are no available evidence-based tools
or interventions demonstrated to improve stimulant adherence and reduce misuse among youth with ADHD.
Most adherence aids (e.g., medication reminder apps, 7-day pill organizers, smart pill caps) fail to ad-
dress the potential misuse of stimulants as they cannot regulate medication access. Pill dispensers are effec-
tive at improving medication safety and adherence, but they are designed for older adult/elderly patients, and
they are not ideal for youth due to their large and heavy size. Our pilot data suggest that youth are concerned
about stigma from others when using their medication, and the use of current dispensers could hinder adher-
ence by potentially soliciting unwanted attention and triggering anticipated stigma (i.e., worry/concern about
negative reactions from others).
PillSmart™ is a primary prevention intervention that uses a novel, sleek, and discreet pill dispensing
device (prototype developed) and mobile app (prototype). PillSmart's pocket-sized pill dispenser aims to pre-
vent misuse by securely storing medication and only dispensing the programmed dose at the scheduled time.
PillSmart's interoperating mobile app aims to improve adherence and mitigate the parental burden by facilitat-
ing remote supervision of the stimulant medication regimen. The overarching goal of this project is to develop
PillSmart's system as an evidence-based prevention intervention to improve adolescents' health outcomes as
they mature into adulthood, reduce caregiver burden, and increase medication adherence and safety.
The aims of our SBIR Phase I project are to fully develop a portable, affordable medication manage-
ment system, test its usability, and assess its feasibility to facilitate self-management of stimulant medications
among adolescents with ADHD, improve medication adherence, and reduce parental caregiver burden. Upon
the completion of the milestones in Phase 1, we will be prepared to transition into Phase II of the research
where we plan to conduct a multisite randomized clinical trial and to integrate evidence-based behavioral ap-
proaches. We anticipate the technology's benefits to apply for adolescents with ADHD and also adolescents
with other chronic health conditions (e.g., depression, anxiety, Type-2 diabetes).

Public health relevance
PillSmart: Narrative Stimulant medications are controlled substances with a high potential for abuse, and the alarming rates of stimulant non-adherence and misuse among adolescents pose a serious public health crisis. Without adequate monitoring by parental caregivers, stimulant misuse and non-adherence among youth can increase the risk of substance use disorder symptoms, psychosis, and suicidality. This project aims to test the feasibility of PillSmart's sleek, affordable medication management system to engage adolescents and improve their adherence while lowering the risks of misuse and reducing caregiver burden.